MHC GENETIC TYPING CORE

Abstract
To enhance the Johns Hopkins University pigtail macaque colony as a research resource for studying multiple
facets of HIV infection, we have concentrated on improving our understanding of pigtail macaque (Macaca
nemestrina) genetics. We continue to identify and study pigtail macaque MHC class I and MHC class II alleles
using state of the art next generation sequencing approaches working in collaboration with Dr. David O'Connor
at the University of Wisconsin. This ongoing effort has discovered novel MHC alleles and defined MHC class I
haplotypes in pigtail macaques. To broaden the scope of our efforts beyond MHC, we have worked with Dr.
Michael Snyder's team at Stanford to generate a de novo assembly of the pigtail macaque genome that used
long-read sequencing technology. This pigtail macaque resource will facilitate use of functional genomics
approaches in SIV studies. Expanding the genetic data available for pigtail macaques will a) increase the
research utility of pigtail macaques and b) assist in genetic management of the JHU colony with guidance from
Dr. Sree Kanthaswamy, a long term collaborator. These goals will be accomplished through two aims under
the direction of Dr. Mankowski. Specific Aim 1 is to continue to characterize pigtail macaque MHC class I and
MHC class II genotypes in JHU colony-born animals using state of the art deep sequencing approaches,
thereby enhancing rigor and reproducibility of SIV/macaque models of HIV. Specific Aim 2 is to improve our
de novo long-read sequencing assembly of the pigtail macaque genome to increase the research value of this
macaque species by enabling functional genomic approaches.